Mechanims of Breast Development and Carcinogenesis

as fresh samples for isolation of normal organoids or breast stem cells. The pathology core will provide normal breast tissue for stem cell studies (Polyak) and for 3-D organoid cultures (Brugge). Freshtumor samples will be provided to establish primary tumor xenograftsin mice Weinberg). In addition, Dr. Richardson will participate in the pathologic comparisons, both molecular and histology, between the parent human tumors and the resultant xenografts. Gene expression array data obtained from human tumors will be used in system interaction analyses of BRCA1 relatedpathways (Livingston). Dr. Richardson will provide both tissue and scientific expertise to analyzefrozen tumor specimens and paraffin tissue microarrays for the expression of BRCA1gene products, including IRIS (Livingston). RELEVANCE (See instructions): Research using actual human breast tissue and breast tumor material will hopefully provide the most relevant answers to pathogenesis and tumor behavior of breast cancer in women. PROJECT/